Continuing Care App for Justice-Involved Individuals with Substance Use Disorders

Abstract
Substance use disorders (SUDs) continue to be one of the most serious public health problems in the US.1
Studies have consistently documented a substantially higher prevalence of SUDs among adults under justice
supervision in the community (i.e., probation/parole) as compared to the general population.2-4 Continuing care
initiatives for individuals with SUDs have gained increased attention with the recognition that substance use
treatment requires long-term care.15, 46, 47, 54-58 Studies show that continuing care interventions can provide
ongoing support or extend primary treatment gains with respect to reductions in substance use, relapse, and
criminal activity.12, 52, 55, 56, 61-63 Recent diffusion of Internet and smartphone technologies among disadvantaged
populations now offers unprecedented opportunities for increasing access to quality continuing care interventions
as well as chronic disease self-management tools. Probationers and parolees at high risk for drug abuse relapse
and involvement in health compromising behaviors are an important population that stands to benefit from
continuing care technologies.
Building on our team’s extensive experience in the fields of criminology and substance use, we propose to
finalize the development of a Continuing Care mobile application (app) by enhancing app capabilities and
conducting a randomized controlled trial to assess its effectiveness among clients on probation or parole who
are enrolled in outpatient substance use treatment. The app is designed to meet the recovery and personal
support needs of probationers and parolees with SUDs who are at elevated risk of relapse, treatment
discontinuation, re-arrest, and incarceration. It is guided by the principles of the transtheoretical model of
behavior change,24 and app content is derived from the Your Own Reintegration System (YOURS) program,25
an empirically-supported26 intervention that focuses on substance use recovery, reducing criminal thinking and
behavior, and cultivating support systems. If proven to be effective, the CC app could be deployed across the
national network of outpatient treatment providers and be highly significant in its direct impact on public health.

Public health relevance
Project Narrative This project seeks to extend the investigator’s successful preliminary work that developed a Continuing Care mobile application (app) for probationers and parolees with substance use disorders (SUDs) who are at elevated risk of adverse health consequences such as relapse, re-arrest, and incarceration. The proposed project will enhance and finalize app development and evaluate its effectiveness in a randomized controlled trial. The project has high public health significance due to its potential to provide an accessible, easy to use recovery support tool for individuals on probation or parole that could improve their SUD treatment outcomes.